Sex Specific Effects of Adolescent Alcohol Exposure on BNST Plasticity

Project Summary/Abstract: Adolescent alcohol use is a known risk factor for the development
of alcohol use disorders (AUDs); latent maladaptive plasticity associated with adolescent use
likely underlies this increased risk in adults. The bed nucleus of the stria terminalis (BNST) is a
sexually dimorphic brain region and critically involved in stress and negative affect-associated
relapse in AUDs, and therefore is a prime target for this maladaptive plasticity. Using a model of
adolescent intermittent ethanol exposure (AIE) in male and female mice, we find disrupted
BNST glutamatergic transmission and plasticity, but the mechanisms differ across sex (GluN2B-
NMDAR-mediated in males and mGluR1/5-mediated in females). When tested during
adulthood, both forms of BNST plasticity return to control levels but exposure to restraint stress
produced a re-emergence of AIE-induced that were sex-specific. AIE also increased glutamate
release in the BNST and this effect appears be mitigated through modulation of presynaptic
CRFR1. AIE and adult stress also produce sex-specific negative affect behavioral phenotypes
(novelty-induced hypophagia test in females, foot shock-induce freezing in males). As the BNST
sits at the intersection between cortical inputs and downstream amygdalar and hypothalamic
targets, this enhanced drive to the BNST and subsequent inter BNST plasticity likely sensitize
the stress response and the expression of negative affect behaviors. Using a combination of
molecular, electrophysiological, genetic, and behavioral approaches, we will evaluate the ability
of AIE to prime the BNST to adult stress sex-specific manner. I hypothesize that that AIE and
adult stress act to synergistically enhance glutamate release in the BNST via activation of
CRFR1 in male mice but not female mice (Aim 1). Modulation of CRFR1 transmission will be
examined for its ability to block the effects of stress on glutamate release and plasticity and
evaluate stress sensitive inputs. Next, I propose that the sex difference in BNST plasticity occur
in distinct projection regions (CeA, LH, or VTA). Finally, BNST-specific deletion, BNST
DREADD activation, and pharmacological antagonism of GluN2B-NMDARs and mGluR5s
(depending on the sex) will be used to assess the role of these receptors in the development of
sex-specific negative affect phenotypes. The goal of this work is to identify potential
pharmacotherapies to treat AUDs and our work suggest that these likely need to be distinct for
males and females.

Public health relevance
Project Narrative Understanding of the development of anxiety/depression during alcohol withdrawal is critical to the prevention of relapse during alcohol abstinence and overall treatment of alcoholism. This project investigates the effects of adolescent alcohol use on a primary neurotransmitter system (glutamate) in key brain areas (the extended amygdala) known to be important for the development of anxiety/depression. These studies also explore differences in the development of these behaviors between sexes.